Dysregulations in Polyamine Metabolism During Atherosclerosis

PROJECT SUMMARY/ABSTRACT
Atherosclerotic cardiovascular disease (CVD) remains the leading cause of morbidity and mortality worldwide.
Furthermore, despite aggressive lipid-lowering strategies, e.g., statins and anti-PCSK9 blocking antibodies, most
individuals still suffer from recurrent myocardial infarctions and strokes. This “residual risk” has now been
attributed to excessive inflammation and pathologic vascular remodeling, cellular events that alter vessel
architecture, drive extracellular matrix degradation, and promote vascular calcification. While directly targeting
inflammation is a challenging approach, as those receiving anti-inflammatory therapies experience a significant
increase in the risk of death due to infection or sepsis, developing strategies that attenuate extracellular matrix
(ECM) degradation and vascular calcification are vital to the next generation of successful cardiovascular
therapeutics. However, the cellular and molecular mechanisms that drive these features of plaque instability
have yet to be fully revealed. Our supporting data herein provide evidence that the polyamine biosynthetic
pathway, which generates amino acid-derived small polycations, becomes dysregulated during atherosclerosis
progression and that impairments in polyamine biosynthesis drive vascular smooth muscle cell (vSMC)
phenotypic modulation. Ornithine decarboxylase (ODC1), the rate-limiting enzyme in polyamine synthesis,
catalyzes the conversion of the amino acid ornithine into putrescine, and our new data identify a critical role for
ODC1-dependent putrescine synthesis in vSMC function during atherosclerosis. We demonstrate that (1)
putrescine synthesis by vSMCs decreases as atherosclerosis progresses in humans, particularly in unstable
plaques, and mice, (2) impairments in putrescine synthesis lead to vSMC phenotypic modulation, and (3) vSMCs
that are incapable of synthesizing putrescine show enhanced degradation of ECM proteins and increased
calcium deposition, features of atherosclerosis that drive plaque instability. Accordingly, these preliminary data
lead us to form the overarching hypothesis that impaired putrescine synthesis in vSMCs drives plaque
destabilization by promoting phenotypic modulation, increasing ECM degradation, and enhancing vascular
calcification. Based on the above premises and our extensive supporting data, we propose that impaired
putrescine synthesis in vSMCs drives plaque destabilization by promoting phenotypic modulation, increasing
ECM degradation, and enhancing vascular calcification. Our main objectives are to (1) define the mechanisms
by which putrescine synthesis promotes vSMC differentiation, (2) determine the mechanisms by which impaired
putrescine synthesis drives extracellular matrix degradation and vascular calcification in atherosclerosis, and (3)
identify the mechanisms that impair putrescine synthesis in vSMCs during atherosclerosis. Successful
completion of these aims will identify the mechanisms by which impairments in putrescine promote plaque
instability and demonstrate that strategies to enhance putrescine synthesis in vSMCs mitigates atherosclerosis.

Public health relevance
PROJECT NARRATIVE Cellular events that alter vessel architecture, drive extracellular matrix degradation, and promote vascular calcification cause atherosclerotic plaque destabilization, ultimately increasing the risk for acute cardiovascular events. Our research identifies that impaired putrescine synthesis in vascular smooth muscle cells (vSMCs) enhance these features of plaque instability. Understanding the mechanisms that impair putrescine biosynthesis in vSMCs during atherosclerosis may provide novel therapeutic strategies to stabilize rupture- prone atheromas.